Project 1: Clinical and immune impact of radiation and dual checkpoint blockade in patients

Project Summary
Immunotherapy has revolutionized the treatment of a variety of advanced cancers, especially immune
checkpoint blockade (ICB). Although newly FDA approved antibodies that block CTLA-4 or PD-1 offer
hope for some patients, not all patients respond, and others relapse after initial response.
Consequently, there is a great importance in evaluating immune checkpoint blockade with other
therapies that trigger immune activation. Based on extensive preclinical and clinical results from our
group, we are focused on the combination of immune checkpoint blockade with hypofractionated
radiotherapy (HFRT). The rationale for this approach is emerging evidence from our group and others
that irradiation of tumors can stimulate the immune system, perhaps by releasing tumor-associated
antigens which may allow for better response to the immunomodulatory agents. In a previous phase I
trial of ipilimumab with HFRT in patients with advanced melanoma, we observed some cases of deep
objective responses, reminiscent of prior case reports, but only in 18% of patients. In extensive
preclinical experiments in which we modeled the interactions of radiation and ICB, we found across
multiple histologies (breast and pancreatic cancer, melanoma) that blockade of CTLA-4 and PDL-1/PD-
1 in combination with HFRT achieved major tumor regressions and complete responses in mice without
major toxicity (Tyman-Saint Victor, Nature, 2015). Both CTLA-4 and PD-L1 blockade are required for
optimal therapy as each modality non-redundantly improves response and immunity. PD-L1 blockade is
especially important to overcome immune resistance, as our data show that efficacy of HFRT plus
CTLA-4 blockade alone is limited by PD-L1 expression in the tumor, a finding validated in samples from
our initial trial. Based on these pre-clinical data, we propose two immediate clinical trials in
collaboration with Core C combining agents that block CTLA-4 (ipilimumab or tremelimumab) or PD-
1/PD-L1 (nivolumab or durvalumab) with HFRT: (Aim 1) a phase 2 randomized trial of ipilimumab and
nivolumab with or without HFRT in patients with metastatic melanoma, and (Aim 2) a phase 1 trial of
tremelimumab and durvalumab in patients with metastatic pancreatic, lung, and breast cancer. In Aim
3, we will apply a comprehensive plan for immune assessment with collaborations across all Projects
and Cores in this P01 to determine the immunological mechanisms of our approach. The expected
clinical and immunological findings will significantly advance the development radiation and immune
checkpoint therapy for patients.
1

Public health relevance
Project Narrative New approved immune checkpoint therapies have been clinically revolutionary, but not all patients respond and others relapse after initial response. Based on extensive pre-clinical and clinical preliminary data, we will perform two immediate clinical trials combining agents that block CTLA-4 (ipilimumab or tremelimumab) or PD-1/PD-L1 (nivolumab or durvalumab) with hypofractionated radiotherapy. A comprehensive plan for immune assessment will determine the immunological mechanisms and resistance of our approach. 1